Serotonin N-Acetyl-Transferase Inhibitors for Circadian Rhythm Disorders

Circadian rhythm (CR) dysregulation contributes to mental health disorders, including major
depressive disorder (MDD), bipolar disorder (BD), and seasonal affective disorder (SAD).
Melatonin has been strongly associated with CR, but despite years of research, many questions
remain regarding its role and how it influences mood. The rate-limiting step in melatonin synthesis
involves the enzyme serotonin-N-acetyltransferase (SNAT, AANAT). Inhibition of SNAT would be
a valuable approach for studying the physiological function of melatonin and could be used to
treat disorders such as SAD that involve abnormally high melatonin. Published inhibitors have
problems with cell permeability, selectivity, and/or potency, which have prevented advancement
to testing in humans. The aims of this project are 1) to identify potent, selective and cell permeable
SNAT inhibitors by virtual screening, and 2) to use structure-guided design to improve potency of
cell permeable SNAT inhibitors. To achieve Aim 1, we will use a more physiologically relevant
SNAT structure than has been used in the past, bound to its chaperone, with a more closed
binding site, which we hypothesize will have greater predictability than previous models for
screening commercial compounds in the ZINC database. As a selectivity filter, we will dock
commercial compounds with high scores for predicted SNAT binding against the anti-targets,
melatonin receptor 1 and 2 (MT1-2), We will also prioritize by calculated properties that correlate
with cell permeability. The top 200 compounds from this virtual screening campaign will be
purchased, and in vitro activity will be evaluated according to a tiered progression scheme.
Compounds with good potency in an enzyme assay (Ki < 10µM) will be advanced to PAMPA for
assessing permeability, and then MT1-2 receptor assays for selectivity. Proof-of-concept efficacy
studies in zebrafish larvae will provide an efficient and validated way to evaluate SNAT inhibition
in a living system. In Aim 2, we will use our model to design new scaffolds based on one of the
few existing drug-like SNAT inhibitors. Also, we expand upon an innovative but insufficiently
studied strategy for forming inhibitors at SNAT’s active site via its alkyltransferase activity.
Powerful kinetic mechanism methods and co-crystal structures of selected inhibitors will be
employed to develop a more complete model of SNAT inhibition, which would be highly impactful
for studying and treating CR disorders.

Public health relevance
Despite strong evidence for the association of melatonin with circadian rhythm and mental health, its function is poorly understood. We seek to develop inhibitors of the key enzyme involved in making melatonin to better understand its function and for use as drug candidates for treating disorders in which it is abnormally high, such as seasonal affective disorder (SAD). Our team will apply computational, mechanistic, and medicinal chemistry approaches to discover and optimize inhibitors to overcome weaknesses of earlier attempts to block melatonin synthesis.